Intelligent wearable system for preventing medication errors in anesthesiology

Project Summary/Abstract
Adverse events associated with injectable medications are estimated to impact millions of hospitalizations
annually with billions of dollars in associated costs and thousands of deaths. Drug administration errors are
the most frequently reported critical incidents in anesthesia with error rates for drug delivery events as high as
5-10% of all drugs given. Accidentally selecting the wrong syringe or vial, or giving an incorrect dose, are
common drug errors. Multiple solutions have been suggested to decrease these errors, however, most
solutions require additional steps prior to drug administration and provider compliance can be problematic. A
real-time auditory or visual feedback system that detects syringe handling by an anesthesia provider could
provide a virtual second set of eyes to check medications before mistakes occur.
This proposal seeks to obtain head-mounted high resolution video footage of anesthesiology providers.
Computer vision algorithms will be developed to identify syringes and vials in real-time. The central
hypothesis of this work is that machine learning algorithms operating from images obtained from a power
efficient camera can accurately identify medications before they are given to patients in the operating room and
generate an electronic medical record which is at least as accurate as current, manually generated tools. (1)
Determine reliability of drug label identification using machine learning tools. Build a database of 7,500-
15,000 syringe handling events obtained from head mounted cameras on 30 providers at two hospitals and
build real time machine learning algorithms to identify syringes, vials, and labels of commonly used anesthesia
medications optimized for timely, accurate identification. (2) Assess accuracy of automated drug delivery
dose calculations. Build volume analysis software to determine the volume of a drug administered as well as
identify the drug concentration to calculate dose. Compare timing and dosages from the manually produced
clinical record to those determined from the computer vision algorithm using the video footage as the true
value to determine the accuracy of each modality. (3) Design and test the feasibility of a power efficient
real-time wearable camera system. A low-cost camera system optimized for all day use with real-time
analysis capabilities will be constructed including two separate cameras, one low and one high resolution to
minimize battery consumption and thus overall device size and weight, recording in high resolution only when
the low-resolution camera detects syringe handling.
Through this K08 award the candidate will learn skills needed to be a leading expert in computer vision,
specifically, as it can be applied to patient safety in anesthesiology.

Public health relevance
Project Narrative Medication errors or adverse events are a major public health problem causing thousands of deaths annually. This proposal aims to build wearable cameras with real-time computer vision algorithms to identify medications when initially selected by an anesthesiology provider during drug preparation or before injection to potentially prevent accidentally giving the wrong drug. Drug dose will also be determined and recorded in an electronic health record, potentially increasing record accuracy and decreasing manual tasks for anesthesiologists so they can focus on direct patient care.